Role of Splenic Pro-Resolving Mediators During Exposure to Particulate Air Pollution

Exposure to ambient particulate matter (PM) is a risk factor for cardiovascular disease. Although the mechanisms
by which PM induces pervasive multi-organ injury are still under investigation, evidence strongly implicates
chronic inflammation as a primary driver of pathology. Whether exposure to fine PM (PM2.5) specifically impairs
the endogenous pathways that promote the resolution of inflammation is not known. Therefore, the long-term
goal of this project is to determine how exposure to PM impacts the resolution of inflammation and whether this
contributes to PM exposure-exacerbated atherosclerosis. In work in progress, we discovered that in mice
exposed to concentrated PM (PM2.5) for 30 days circulating erythrocytes expressed markers of premature aging
and oxidative damage. In the spleens of these mice there was an expansion of the population of cells responsible
for erythrocyte disposal, red pulp macrophages, while pathways related to erythrocyte turnover, heme
metabolism, and iron cycling were upregulated. Additionally, we found that several factors related to
hematopoiesis were induced in the tissue. These alterations were accompanied by a marked decrease in the
abundance of specialized lipid mediators that promote resolution (SPMs) and their receptors. The changes in
spleen are particularly critical because the spleen plays a central role in regulating immune response dynamics.
It houses an important and distinct reservoir of monocytes, which can be rapidly mobilized and deployed in
response to various insults. In addition to coordinating immune function, the spleen acts as a filter to remove
senescent and damaged erythrocytes. Though patients survive following splenectomy, they are more likely to
contract serious and life-threatening infections and have heightened risk of developing hematological
malignancies and coronary artery disease among other disorders. Our preliminary studies suggest that exposure
to PM2.5 may disrupt splenic homeostasis with targeted impacts on red pulp macrophages. As macrophages are
the critical facilitators of erythrophagocytosis, maintenance of the splenic hematopoietic niche, and SPM actions,
our central hypothesis is that PM2.5 exposure increases splenic macrophage erythrophagocytosis, which
suppresses SPM production and permits local myelopoiesis, thereby enhancing monocyte egress and
exacerbating vascular inflammation. To test this hypothesis, we will examine the effects of PM2.5 exposure on
splenic macrophages, determine the impact of PM2.5 exposure on the splenic hematopoietic niche and delineate
the contribution of splenic myelopoiesis to PM2.5-exacerbated atherosclerosis. This project will elucidate the
effects of PM on the resolution of inflammation and will provide a new mechanism by which exposure to PM
establishes a state of chronic, non-resolving inflammation that affects multiple organs and processes.

Public health relevance
Chronic exposure to ambient particulate matter (PM) leads to systemic inflammation and cardiovascular disease. Promoting the endogenous active mechanisms of resolution may interrupt persistent inflammatory inputs induced by PM. Here, we will assess the impacts of PM exposure on the cellular facilitators of resolution and determine whether their response to PM governs systemic immunity.